Bruker timsTOF fleX MALDI-2 LC MS System

PROJECT SUMMARY
A group of 23 NIH-funded investigators from Baylor College of Medicine (BCM) is requesting funds to acquire a
timsTOF fleX MALDI-2 imaging mass spectrometry (IMS). The IMS platform will be a new platform to BCM and
will substantially enhance the current and pending research projects of the involved investigators as well as
other faculty in the Texas Medical Center. The requested timsTOF fleX MALDI-2, which can exploit Trapped
Ion Mobility and MALDI-2 ionization make this mass spectrometer the best suited instrument for the proposed
studies. Two primary applications of the timsTOF fleX MALDI-2 platform are envisioned: 1. the mapping of
lipids and other endogenous metabolites to reveal their tissue spatial distributions in health and disease, and 2.
the mapping of xenobiotics to study the spatial distribution of drugs and drug metabolites in pharmacokinetic
studies (e.g., monitoring the process of xenobiotic absorption of intestine). Samples of interest include model
organisms such as, Drosophila melanogaster, mouse and rat, as well as organoids. The platform will be used
to map endogenous metabolites in the brain, heart, liver, pancreas, spleen, bone marrow, ovaries, and testes
of wild type and mutant mice; and to develop new probes to improve ionization of certain molecules. The
research programs that will benefit from the IMS platform are highly diverse and funded by 55 NIH grants, 2
DoD grants, 3 NASA grants, and 2 HHMI grants. Currently, the 16 major users and 7 minor users has
expressed interest in the IMS platform. The individual instruments that comprise the IMS platform will be
located in and managed by the NMR and Drug Metabolism Core under the auspices of the Institutional
Advanced Technology Cores at BCM. Currently, the only available access to IMS in Dr. Livia Schiavinato
Eberlin’s laboratory used for her own research and clinical related studies (e.g., IMS pen), which has reached
its capacity. The IMS platform not only empowers the individual research programs at BCM, but it also
facilitates access to this new technology that is critically needed by investigators at institutions within the Texas
Medical Center and in the greater Houston area and fosters collaborative research and provided an important
regional resource.

Public health relevance
PROJECT NARRATIVE The NMR and Drug Metabolism Core at Baylor College of Medicine (BCM) provides state-of-the-art innovative and versatile quantitative LC-MS-based drug metabolism and pharmacokinetics services. To address the growing demand for imaging spatial distribution of endogenous molecules of interest, drug, and drug metabolites in the BCM and Texas Medical Center biomedical research communities, we request funding for the timsTOF fleX MALDI-2 mass spectrometer. Prospective users of this platform are engaged in highly diverse research and are funded by NIH, DOD, NASA as well as HHMI. The Imaging Mass Spectrometry platform is expected to enhance the BCM faculty’s studies of the brain, heart, liver, testes, ovaries, and cancers in multiple model organisms as well as drug development.